UCSF Diabetic Foot Clinical Research Unit

PROJECT SUMMARY/ABSTRACT
Diabetes prevalence continues to rise globally, with more than 37 million individuals (11% of the population)
currently affected in the United States. Approximately 15-20% of these people will experience a diabetic foot
ulcer (DFU) at some point in their lives, with significant impact on quality of life, morbidity, and mortality. DFU
are a harbinger of lower extremity amputation which occurs in approximately 150,000 Americans annually.
Despite advances in wound care and related technologies, delayed healing and high recurrence rates of DFU
remain major clinical challenges in current practice and create an enormous burden on patients and the
healthcare system. In 2018 the NIDDK established the Diabetic Foot Consortium to address this large unmet
need by execution of high quality, multi-center studies in DFU subjects with a focus on biomarker development
and validation. The UCSF Diabetic Foot Clinical Research Unit (CRU) is one of the six initial participating
centers in the DFC. Among its accomplishments, the DFC has executed two ongoing biomarker validation
trials, initiated a biorepository protocol, reviewed multiple ancillary study proposals, and is currently finalizing a
master protocol to enroll any patient with an incipient DFU. In its next renewal period, these DFC efforts will be
expanded to include new candidate biomarkers, examine standard of care practices through a new master
protocol, incorporate social determinants of health (SDOH), execute ancillary studies, and augment the
recruitment of a diverse population by engagement of satellite sites.
The UCSF Diabetic Foot CRU consists of two major affiliated medical centers- UCSF Medical Center and
Zuckerberg San Francisco General Hospital- linked to satellite podiatry clinics in the Bay Area that share a
research umbrella organization (Center for Clinical Research; CCR). Over the last year we have been able to
expand subject recruitment for DFC trials dramatically by the incorporation of CCR clinics. We have also
initiated pilot feasibility studies to incorporate SDOH collection within the currently ongoing biomarker trials (c-
Myc and TEWL). During the next 5 year funding period, our multi-disciplinary research team will further
contribute to the DFC by activation of a new common Master Protocol inclusive of all patients with an open
DFU, incorporate the collection of SDOH data and examine its associations with outcomes, and expand the
infrastructure through the addition of CCR clinical performance sites.

Public health relevance
PROJECT NARRATIVE This proposal is a renewal for the UCSF Diabetic Foot Clinical Research Unit, one of the original centers within the NIDDK Diabetic Foot Consortium. In the next funding cycle, our multi-disciplinary team will continue to recruit subjects from our two academic hospitals (UCSF Medical Center and ZSFGH) into the DFC trials, operationalize a new master protocol to enable the study of all patients with active diabetic foot ulcers (DFU), expand our infrastructure through an existing partnership with affiliated Bay Area podiatry clinics, and initiate the study of social determinants of health (SDOH) within the DFC. This research directly addresses a major public health burden in the Bay Area, nation, and global community.